The regulatory landscape of segmentally duplicated genes: Implications for human evolution and disease

Contact PD/PI: Vollger, Mitchell
PROJECT SUMMARY
Objective and Specific Aims: This project seeks to comprehensively understand how gene regulatory elements
within rapidly evolving areas of the human genome, segmental duplications, influence human evolution and
disease. Despite their potential significance, these regions have historically been challenging to study due to
technical limitations. The specific aims of this project are:
1. Characterize segmental duplications across the human population by constructing a pangenome graph
using thousands of high-quality genome assemblies.
2. Establish a statistical and computational methodology for mapping regulatory DNA within SDs using long-
read chromatin fiber sequencing (Fiber-seq).
3. Identify conserved regulatory and genomic elements within segmental duplication loci by mapping
genetic and epigenetic haplotypes into the pangenome graph.
4. Uncover the regulatory fate of multi-copy gene families by analyzing segmental duplication paralogs with
Fiber-seq across tissues, determining if these paralogs have undergone changes in regulatory function.
Relevance to the Agency's Mission: This research directly aligns with the institute’s mission to understand the
genetic underpinnings of human evolution and disease. SD regions, due to their rapid evolution and complexity,
have remained challenging to study. Yet, they hold invaluable insights into human-specific genetic adaptations
and susceptibilities to diseases. Identifying and characterizing regulatory elements in these fast-evolving
genomic regions will offer novel insights into human-specific traits, as well as potential vulnerabilities to diseases.
Research Design and Methods: In this work, I will create a comprehensive SD pangenome graph by integrating
thousands of long-read haplotypes from multiple consortia, which will significantly enhance our understanding of
human variation within SDs. Next, I will use long-read Fiber-seq in conjunction with the development of a
machine-learning framework to detect regulatory elements within SDs and use that information to impute the
results of other short-read epigenetic assays. My approach will also involve a conservation analysis that
prioritizes SD genes and regulatory elements. I will introduce a novel 'loss-of-paralog intolerance' (pLPI) score
to rank these genes based on their conservation levels across populations. Additionally, the regulatory
trajectories of SD genes will be determined using Fiber-seq conducted on a range of human tissues. This will
help me identify distinct patterns such as neofunctionalization, subfunctionalization, or pseudofunctionalization.
This investigative approach will deliver an in-depth understanding of the regulatory mechanisms in SDs using
cutting-edge genomic tools. The insights gained have the potential to highlight human-specific regulatory
adaptations and could pave the way for discovering new therapeutic avenues in personalized medicine.
1

Public health relevance
Contact PD/PI: Vollger, Mitchell PROJECT NARRATIVE This research aims to decode the regulatory elements in fast-evolving regions of the human genome, segmental duplications, shedding light on their roles in human evolution and susceptibility to diseases. By understanding these genetic components, the findings could pave the way for novel therapeutic targets and improved health outcomes. Ultimately, this project seeks to enhance knowledge about the functional contribution of duplications to the human genetic makeup, with the potential to uncover mechanisms of disease and adaptation in these unique regions. 1